Response To Immune Associated Stress

Abstract:
Not required per PA-21-071; see Research Strategy section for summary of the funded parent
award or project.

Public health relevance
Project Narrative: Not required per PA-21-071; see Research Strategy section for summary of the funded parent award or project.